Mural cells contribution to vascular remodeling in flow induced pulmonary hypertension

Project Summary/Abstract: Pulmonary arterial hypertension (PAH) is a progressive vascular disorder
characterized by narrowing and remodeling of the distal arterioles. Current treatment options are unable to
prevent disease progression, leading to a median survival time of five years after diagnosis. Therefore, there is
an urgent need to develop new disease-modifying therapies. Increased pulmonary blood flow is known to
stimulate vascular remodeling in patients with congenital heart disease (CHD) and after major lung resection,
although the underlying mechanism is unclear. Patients with left-to-right shunts such as ventricular septal defects
and atrioventricular canal defects are at high risk for PAH. A “second hit” in the context of pulmonary
overcirculation, such as hypoxia, may lead to irreversible vascular remodeling and disease progression. Current
rodent models of flow-induced pulmonary hypertension (PH) such as the left pneumonectomy and SUGEN rat
do not fully recapitulate patients' physiological conditions. To improve patient outcomes, animal models more
representative of patients are needed, along with a better understanding of the underlying molecular
mechanisms.
My goal is to generate a novel animal model to study flow-induced PH. Establishing a murine model of
PH that mimics patients with CHD will enable the development of therapeutics capable of reversing flow-induced
vascular remodeling. The second goal of this proposal is to discover key insights into the response of smooth
muscle cells (SMCs) to vascular remodeling from increased pulmonary blood flow. Specifically, the aims of this
proposal are to 1. Develop a new mouse model of flow-induced PH that better represents patients' physiological
conditions, 2. Describe the contribution and underlying mechanisms in which SMCs contribute to shear stress-
induced vascular remodeling, and 3. Discover novel therapeutic approaches for patients with PAH-CHD.

Public health relevance
Project Narrative: At present, no disease-modifying therapies exist for patients with pulmonary arterial hypertension. While it is known that increased pulmonary blood flow can lead to structural changes in the distal arterioles, the underlying mechanisms remain unclear. My study will provide novel insights into the contribution and involvement of smooth muscle cells to flow-induced vascular remodeling. Additionally, my work will establish new murine models that will provide a valuable resource for future researchers investigating pulmonary hypertension.